Bridges to the Doctorate Research Training Program at CSU San Marcos with UCSD and TSRI

PROJECT SUMMARY
As a young, rapidly growing campus in North San Diego County, California State
University San Marcos (CSUSM) is well-positioned to prepare motivated students from
underrepresented (UR) groups for graduate studies and research careers. A large
proportion of CSUSM students is Hispanic (47%), which exceeds the non-Hispanic White
population (27%). The campus is a Hispanic Serving Institution (HSI). In addition, 54%
are from families in which they will be the first to complete a college degree and 52% are
Pell Grant recipients. Thus, CSUSM is home to a rapidly growing diverse student body,
many of whom are low income and/or the first in their family to attend college.
The Bridges to the Doctorate Research Training Program at CSU San Marcos with
UCSD and TSRI (B2PhD) has been specifically developed to meet the needs of the
student population at CSUSM. The program will use evidence-based practices to achieve
the following 8 objectives: 1) prepare, recruit and select scholars who show significant
promise for success, 2) enhance quantitative and methodological skills, 3) enhance
scientific communication skills, 4) engage students in meaningful biomedical research
that results in thesis and publication(s), 5) develop knowledge, skills and persistence
necessary to succeedin a doctoral program and beyond, 6) expose students to a
culturally validated pedagogy to increase belonging and persistence, 7) to prepare
competitive applications for graduate school, and 8) reduce time to degree in both
Master’s and PhD settings. The program is two years in length. We propose to engage 8
master’s students in year 1 of the program, and 16 in years 2-5.
Our major goals, informed by past success rates, are for 90% of CSUSM B2PhD Scholars
to graduate with their master’s degree and 70% to enter PhD programs. Taken as a whole,
the B2PhD Program, in concert with a highly supportive campus environment, will prepare
students from UR groups to be thoughtful scientists who have the knowledge, skills, research
experience and character that prepare them for doctoral studies in the biomedical and
behavioral sciences and that allow them to become future leaders in science and academia. By
doing this we will help advance the goals of the National Institutes of Health to diversify the
research workforce. A more diverse research workforce will better address the research needs
of a diverse nation and thereby contribute to better health for all.

Public health relevance
PROJECT NARRATIVE The Bridges to the Doctorate Research Training Program at CSU San Marcos with UCSD and TSRI will prepare students from underrepresented (UR) and disadvantaged groups for careers in biomedical and behavioral research and will serve to advance the goals of the National Institutes of Health to diversify the research workforce. A more diverse research workforce will better address the research needs of a diverse nation and thereby contribute to better health for all.